Flexible Funding Model Infrastructure Development & Maintenance

Project Summary/Abstract
The Indiana State Department of Health (ISDH) Food Protection Program pursues this funding
opportunity to continue its work on the Manufactured Food Regulatory Program Standards
(MFRPS), Rapid Response Team (RRT), and Food Protection Task Force (FPTF). These
initiatives promote the development of a high-quality food regulatory program which includes a
uniform basis for measuring and improving the performance of prevention, intervention, and
response activities. Conformance with these initiatives allow the program to focus on risk and
prevention, rather than event and reaction, and ensures program consistency, and promotes
continuous quality assurance and improvement efforts. These initiatives also promote a national
Integrated Food Safety System (IFSS) which is mandated by the Food Safety Modernization Act
(FSMA).
The ISDH Food Protection Program has implemented MFRPS, but has determined that this
quality improvement system has not been fully integrated into the program's culture. The
program must find more sustainable methods to conform to and maintain these standards. A
funded RRT in Indiana has been established for two years, and the program looks forward to
more fully developing and sustaining Indiana's RRT. The Indiana Food Safety and Defense
Task Force began under another name in 2003, and continues to advance by broadening
outlooks and strengthening partnerships.
The mission of the Indiana State Department of Health is to promote and provide essential
public health services; the vision is a healthier and safer Indiana. The agency does so with
laboratory, epidemiology, and food protection professionals. This funding opportunity will aid the
ISDH Food Protection Program agency in strengthening the agency's and state's capability to
prevent, investigate, and mitigate food and feed emergencies through assessment, policy
development, and quality assurance, and training/educational activities. It also provides the
capability to better direct food safety and regulatory activities to reduce foodborne illness
hazards. Finally, an IFSS represents a seamless partnership among federal, state, local,
territorial, and tribal agencies to achieve a safer food supply. While the ISDH Food Protection
Program has established many necessary partnerships, there is still room for improvement.

Public health relevance
Project Narrative Participating in the Manufactured Food Regulatory Program Standards (MFRPS), Rapid Response Team (RRT), and Food Protection Task Force (FPTF) enhances the Indiana State Department of Health Food Protection Program's capability to further develop and sustain a high-quality food regulatory program. These initiatives promote program consistency, quality assurance, and continuous improvement efforts which are necessary to protect Indiana's public from foodborne illness and injury. This cooperative agreement opportunity will strengthen the program's focus on risk and prevention, rather than event and reaction, and encourages partnerships to create a national Integrated Food Safety System for a safer food supply.